Improving Patient-Centered Decision-Making for Stress Urinary Incontinence Treatment in Older Men

PROJECT SUMMARY/ABSTRACT
This is a Beeson K76 career development award for Dr. Lindsay Hampson, a clinician investigator with a
background in ethics, health services research, and stress urinary incontinence (SUI). Dr. Hampson is
pivoting her career towards aging, with a goal of becoming a national leader in geriatric urology research
focused on achieving goal-concordant care for older adults with urologic issues that affect quality of life (QOL)
through reducing treatment disparities and improving treatment decision-making. This proposal seeks to
improve goal-concordant management for post-prostatectomy SUI among older adults by: 1) identifying
drivers of disparities in the care of older post-prostatectomy men, 2) determining treatment preferences and
priorities of this patient population, and 3) promoting individualized evaluation and treatment decision-making
in the context of geriatric-informed health and values. Significance: Post-prostatectomy SUI significantly
impacts QOL, disproportionately impacting older men. Despite a focus on reducing treatment of prostate
cancer, one quarter of men 65-75 years of age diagnosed with prostate cancer will still undergo prostatectomy.
An estimated 25-30% of men are using pads, diapers, or complaining of bothersome incontinence beyond one
year following prostatectomy, and these rates likely represent underestimation of continence rates in older
men. SUI surgery has been shown to result in near-term QOL improvements with high satisfaction rates, yet is
severely underutilized and delayed, and men facing treatment decisions have substantial decisional regret. In
Aim 1’s national cohort study using Veterans Affairs and Medicare data, we aim to identify factors associated
with post-prostatectomy SUI under-treatment and treatment delays among older men. In Aim 2’s discrete
choice experiment survey of older post-prostatectomy men, we aim to identify patient-centered SUI treatment
priorities and understand how these preferences vary based on characteristics associated with access to care.
These data will be utilized to develop an Incontinence Post-Prostatectomy Assessment & Decision Support (I-
PADS) tool which will be evaluated in Aim 3 through a mixed methods study and feasibility/acceptability trial.
Mentoring team: Dr. Hampson’s exceptional multidisciplinary mentoring team is led by Dr. Louise Walter, an
internationally recognized expert on individualized decision making for in older adults. This award will support
Dr. Hampson’s transition to aging research through dedicated training in 1) conducting national cohort
studies of older adults, 2) developing expertise in measuring treatment preferences, 3) implementation science
theory and methods to implement interventions for older adults, and 4) leadership in geriatric urology to
become a leader in goal-concordant urologic care among older adults by reducing treatment disparities and
improving treatment decision-making. Next Steps: These results will serve as the foundation for a multicenter
hybrid implementation-effectiveness study of the I-PADS tool to test its effect on addressing disparities in SUI
surgery, decisional and treatment regret, and receipt of goal-concordant care for post-prostatectomy SUI.

Public health relevance
PROJECT NARRATIVE: Male stress urinary incontinence (SUI), a frequent result of radical prostatectomy for prostate cancer, significantly reduces health-related quality of life among older men. Surgical treatment options are known to provide near-term improvement in quality of life with high satisfaction rates but are underutilized and patients have regret about treatment decisions. The goal of this K76 proposal is to improve goal-concordant treatment decisions for SUI management in older men by identifying disparities in surgical care and addressing these disparities by developing a geriatric-informed patient-centric decision support tool to promote individualized, goal-concordant decision-making for SUI treatment decisions among older men, which will then be tested in an R01 multi-institutional implementation-effectiveness trial.